Arizona Department of Health Services Laboratory - Chemistry Tract 2: Human Product Food Testing

Chemistry Track 2 ? Human Food Product Testing Narrative The Arizona Department of Health Services Laboratory (ASPHL) is the MFRPS Laboratory in Arizona and proposes to engage in human food product testing from both retail grocers and food manufacturing facilities within the state. In coordination with the FDA the ASPHL will collect and analyze 1,600 surveillance samples for Toxic Metals and Allergens under ISO 17025 QA oversight and plans to increase capacity and function in years 3-5 to include compliance pesticide residue and/or compliance veterinary drug and/or compliance mycotoxin testing.